Developing a Nanopore Tweezer Toolkit for Analyzing Kinase Structural Dynamics and Screening Allosteric Inhibitors

PROJECT ABSTRACT
Protein nanopores are powerful sensors that enable a new class of single-molecule
measurements, with applications ranging from fundamental science to commercial DNA
sequencing. Our focus is on developing and applying novel nanopore approaches to tackle
challenges in protein analysis, ultimately improving disease diagnostics and therapeutics. In this
project, we are creating innovative nanopore tweezers capable of real-time tracking kinase
movements triggered by ligand or inhibitor binding at a 100-microsecond resolution for tens of
minutes at the single-molecule level. This work will generate comprehensive energetic maps of
the conformational states of disease-associated kinases during substrate binding, catalytic
activity, allosteric regulation, and inhibition. Overall, this study will introduce new tools and
opportunities for studying structural dynamics, single-molecule enzymology, drug discovery, and
personalized precision medicine.

Public health relevance
PROJECT NARRATIVE The project aims to develop a set of nanopore tweezers to study the motions of kinase proteins in an effort to inform drug design and screen for cancer therapeutics. The nanopore tweezers platform, operating independent of the enzyme activity, will also provide a new paradigm for label-free, single molecule and high-throughput drug screening.